The role of neuronal hyperexcitability and proteostasis in Alzheimer's disease

Key prodromal events in Alzheimer’s disease (AD) revolve on altered electrical signals and buildup of
garbage proteins in vulnerable areas before signs of AD (locus coeruleus, LC)) and as disease progresses to
brain regions that govern memory (hippocampus, HPC) as disease severity increases. This study bridges the
potential lifespan of disease progression using a mouse model of AD pathology to examine how modifications
in brain activity can lead to disease. The LC, while not traditionally associated with AD, is the site of some of the
earliest pathology in AD, as early as people in their 20s. It is also an area regulating flight or fight response and
arousal. In AD, the hyperexcitation or unregulated arousal (hyperarousal) may be a key event in moving the
disease from areas like the LC, or another area with early pathology, the entorhinal cortex (EC) to the
hippocampus or other cortical regions that are more commonly associated with Alzheimer’s.
In AD, the accumulation of aggregated proteins due to altered cellular processes, specifically, the
regulation of protein life cycle (proteostasis) and dysfunction of autophagic-lysosomal and ubiquitin-proteasomal
systems is a key feature of neuropathology. These processes are responsible for clearing the garbage in cells
and declines with age and is accelerated in disease. While we know loss of proteostasis can impair cellular
function, how it can impede neuronal activity has not been well advanced. In this application, we propose that a
primary event early on is the alteration of neural networks in the LC (and EC), leads to the pathological hallmarks
of AD including hippocampal pathology. Demonstrating hyperactivation and proteostasis deficits in the LC as
instigators of hippocampal pathology, particularly, selective neuronal loss provides mechanistic insight as to why
these are key neural network changes in disease.
To model Alzheimer’s pathology, we focus on the LC and HPC to identify how these regions are disrupted
when proteostasis slows down and how hyperexcitation impacts these functions. We will track early
electrophysiological changes in the LC and HPC when proteins like beta-amyloid (A) and tau start accumulating
and assess hyperarousal/excitation using electrophysiological measurements. Over time, hyperexcitation
reduces clearance of aberrant proteins resulting in a positive feedback loop of proteostasis loss and
hyperarousal, and cascade to hippocampus and memory loss. We identify the type of neurons that are most
vulnerable to hyperexcitation/arousal-proteostasis changes in this network, destabilizing excitatory-inhibitory
homeostasis. Finally, we test if dampening hyperexcitation or proteostasis restoration improves cognitive
function and reverses pathological changes in our model. Our goal is to use observations from all the paradigms
to identify if these biological changes and pathological spread of disease can be analyzed using computational
tools to predict the patterns and events leading to AD and to test if we can use as a disease risk score.

Public health relevance
Evidence is mounting that neuronal hyperexcitability during the progression of Alzheimer’s disease (AD), can initiate decades prior to canonical memory loss and associated neuropathology. This proposal will model the dynamic relationship between hyperexcitation/hyperarousal and protein build up of tau and amyloid to understand how selective brain areas, like the locus coeruleus, are impacted early in disease. It will also demonstrate how this can lead to hippocampal dysfunction causing cognitive loss and will attempt to reverse pathological phenotypes by treating proteostasis deficits and ameliorating early stage neuronal hyperexcitation.